Anti-epileptogenic role of mTOR activation among hippocampal interneurons

PROJECT SUMMARY
Epilepsy can be a debilitating and sometimes fatal disease for which there are no preventatives, no
cure, and for which existing medications fail in one third of patients. Development of preventative treatments
for epilepsy is a key NINDS goal (Benchmark II. Prevent epilepsy and its progression; Galanopoulou et al.,
2016; Binder et al., 2020). The mechanistic target of rapamycin (mTOR) pathway has emerged as a promising
target for epilepsy prevention. mTOR acts as a relatively ubiquitous promotor of cell growth; enhancing
neuronal connectivity, excitability and metabolism. Activation of the mTOR pathway occurs during
epileptogenesis and appears to regulate pro-excitatory changes implicated in the process. Moreover, blocking
mTOR signaling with the antagonist rapamycin mitigates epilepsy development in many epilepsy models.
Blocking mTOR signaling, however, does not work in all models, and there is evidence that this pathway may
also act to reduce brain excitability. To explain these conflicting effects, we hypothesize that increased mTOR
activation among excitatory neurons is pro-epileptogenic, while activation among GABAergic interneurons is
anti-epileptogenic. Systemic mTOR antagonists, therefore, block epileptogenic changes among excitatory
cells, but also block compensatory protective changes among interneurons. To test this hypothesis, we will use
intersectional genetic approaches to selectively delete the obligate mTOR regulatory proteins Raptor or Rictor
from vesicular GABA transporter-, parvalbumin-, and somatostatin-expressing interneurons in mice. We will
also examine the impact of enhancing mTOR signaling in interneurons by deleting the mTOR negative
regulator Tsc2. Studies will be conducted using both acquired and genetic models of epilepsy. We predict that
blocking mTOR signaling in interneurons will make epilepsy worse, while enhancing signaling will improve
outcomes. Studies will advance understanding of the role of mTOR in epileptogenesis and will have direct
implications for ongoing clinical use of mTOR antagonists.

Public health relevance
PROJECT NARRATIVE A class of drugs known as mTOR antagonists has recently emerged as a promising treatment for epilepsy, but these antagonists are not effective in all patients, and preclinical studies have found mixed effects in models of epilepsy. We hypothesize that the utility of these drugs is limited because they have opposing effects in excitatory and inhibitory brain cells - they restrict abnormal growth of excitatory cells, which limits epilepsy, but they also restrict the growth of inhibitory cells, which makes epilepsy worse. We propose a series of experiments that will test this hypothesis that, if correct, will provide new guidance on how to develop and improve the efficacy of this promising drug class.